Low-Burden High Fidelity Obstructive Sleep Apnea Screening Using Oral Cavity Images

PROJECT SUMMARY
Obstructive Sleep Apnea (OSA) is a pervasive sleep disorder that affects about 70 million adults in the US and
almost 1 Billion people globally, with an even larger estimated population of OSA patients who are
undiagnosed. Obtaining treatment for OSA and preventing the onset of severe comorbidities is heavily
dependent upon the early identification of symptoms through patient screening. However, current OSA
screening solutions are limited in utility and scope and generally pose affordability, availability, and scalability
challenges. One approach to improving OSA screening is through examination of the oral cavity. Deviations in
oral cavity anatomy, including enlarged tonsils, elongated uvula, low-hanging or thickened soft palate, enlarged
tongue (macroglossia), low visibility of the oropharynx (Mallampati), as well as bruxism and narrow dental
arches (e.g., malocclusions) can directly relate to the occurrence of OSA. As such, dentists have been a critical
component of OSA screening and care for several decades and oral cavity screenings are part of many
clinicians’ physical evaluations for OSA. However, reliance on dentists and clinical evaluations of the oral
cavity maintains the bottleneck of physician availability in limiting patient access to OSA screening. To address
this need, Soliish is developing a novel digital tool for democratizing OSA screening at the population level.
Our mission is to improve early detection of OSA and support clinical decisions during follow-up care. Soliish’s
OSA Screening solution is an innovative digital platform that uses a deep learning model, OSA Net, to deliver a
cost-effective, non-invasive, user-friendly, and privacy-preserving experience that outperforms outdated
screening questionnaires. Unlike other artificial intelligence (AI) or deep learning models which rely upon
medical imaging of the oral cavity to predict OSA risk, our models utilize native images captured on a user’s
smartphone at multiple angles -- all through a single peripheral-free platform. Here, Soliish aims to build upon
the successes of their prior models for craniofacial OSA screening to include automated 2D image analysis of
the oral cavity – this approach will improve the accuracy of our current OSA risk assessment models and
enable us to capture features predictive of OSA likelihood that are not visible from the exterior. We will
separately train and evaluate three models classifying Mallampati scores, malocclusion types, and
macroglossia. Completion of these objectives will result in a comprehensive suite of models capable of
analyzing anatomical structures within the oral cavity and independently predicting OSA likelihood. Success at
this stage will support subsequent Phase II activities focused on amalgamating individual model predictions
and evaluating cumulative model performance using data collected directly from patients in a clinical study with
our partners.

Public health relevance
PROJECT NARRATIVE Obstructive Sleep Apnea (OSA) is a debilitating sleep disorder that is largely undiagnosed and affects 70 million people in the US. To reach those with undiagnosed OSA, Soliish is developing a low-cost digital OSA Screening tool to perform OSA risk assessment using 2D images of the intraoral cavity. Our models have the potential to vastly increase access and accuracy of OSA screening to improve the lives of millions of Americans living with undiagnosed OSA who struggle with a good night’s sleep.